CORE--CENTRAL INSTRUMENTATION CORE FACILITY

The major goal of the Central Instrument and Administrative Core facility is to provide services, materials, and equipment that are commonly used by all the Investigators on the project. The Core Director, Dr. Jungalwala, will administrate the facility with the help of a Laboratory/Administrative Co-ordinator, Ms. Denise Brescia. The facility will have responsibilities to conduct and arrange scientific and administrative meeting with the program Investigators as well as inside and outside scientific advisors; coordinate, manage and maintain central equipment, supplies and repair issues; maintain records, handle correspondence and provide data processing and secretarial services. These services are needed to achieve the scientific goals of the program in efficient and cost effective way